Gene therapy for SCID-X1 with low dose busulfan and a SIN-lentiviral vector

Project Summary
Gene therapy using autologous CD34+ cells is a promising treatment for primary immunodeficiency, particularly
for individuals without optimal allogeneic donors. SCID-X1 is caused by mutations in IL2 Receptor Gamma
(IL2RG) which encodes the common gamma chain (γc) of multiple cytokine receptors. Boys with SCID-X1 lack
T and NK cells and their B cells fail to produce antibodies due to the lack of functional IL-7, IL-15 and IL-21
signaling. This renewal application seeks to complete our currently funded Phase I/II clinical trial that addresses
two major shortcomings of previous GT using gamma retrovirus (γRV) and self-inactivating (SIN)-γRV vectors,
namely lack of B cell reconstitution and insertional mutagenesis. We hypothesize that this trial will improve
immune reconstitution through the introduction of low dose busulfan conditioning (Aim 1) and improve safety
through the change from a gammaretroviral (γRV) vector used in previous trials to the LV vector in this trial (Aim
2). Previous trials of gene therapy for SCID-X1 have infused cells without chemotherapy conditioning, which
resulted in robust T cell recovery and gene marking, but negligible gene marking in B cells and failure of humoral
immune reconstitution. Initial development and marking in NK cells was also not sustained. In Aim 1, we will
examine the impact of low dose busulfan conditioning on 1) cell type specific engraftment and gene marking, 2)
in vivo T cell reconstitution, T cell phenotype and TRB repertoire by deep sequencing, 3) in vivo humoral immune
reconstitution, B cell number, phenotype, IL-21 dependent function and IGH repertoire by deep sequencing, 4)
NK cell number, phenotype and function. Previous trials of gene therapy for SCID-X1 have used a γRV vector
with intact viral promoters/enhancers, which resulted in 6/20 patients developing T cell leukemia due to
insertional oncogenesis. Gene therapy using an enhancer deleted, self-inactivating yRV (SIN-γRV) vector funded
by NIAID in which viral enhancers have been deleted shows encouraging evidence of reduced insertion sites
near lymphoid oncogenes and safety, but the insertion site pattern characteristic of γRV may still be risky. The
proposed trial in this application will seek to further improve safety by using a self- inactivating LV vector. In Aim
2 we will investigate the insertion site pattern in the patients’ engrafted cells, compare samples from this current
trial to previous trials using γRV and SIN-γRV to delineate clustering of insertion sites in specific genes and the
effect of vector backbones on clonal dynamics and expansions.

Public health relevance
Project Narrative We have conducted a gene therapy clinical trial using a unique lentivirus vector funded by our previous NIAID U01 (1U01AI125051) with the addition of low dose busulfan conditioning that has shown excellent results and to date no evidence of safety issues. In this new U01 application, we propose to follow the latest enrolled patients on this SCID-X1 trial (NCT03311503) for protocol-defined immunologic and safety studies, including vector insertion site analysis (ISA), up to the 2 year follow-up time point. We seek to exploit the data generated by ISA for new studies of the biological features of hematopoietic cell reconstitution.